Optimizing BCI-FIT: Brain Computer Interface - Functional Implementation Toolkit

SUMMARY
Many of the estimated four million adults in the U.S. with severe speech and physical impairments (SSPI)
resulting from neurodevelopmental or neurodegenerative diseases cannot rely on current assistive technologies
(AT) for communication. During a single day, or as their disease progresses, they may transition from one access
technology to another due to fatigue, medications, changing physical status, or progressive motor dysfunction.
There are currently no clinical or AT solutions that adapt to the multiple, dynamic access needs of these
individuals, leaving many people poorly served. This competitive renewal, called BCI-FIT (Brain Computer
Interface-Functional Implementation Toolkit) adds to our innovative multidisciplinary translational research
conducted over the past 11 years for the advancement of science related to non-invasive BCIs for communication
for these clinical populations. BCI-FIT relies on active inference and transfer learning to customize a completely
adaptive intent estimation classifier to each user's multiple modality signals in real-time. The BCI-FIT acronym
has many implications: our BCI fits to each user's brain signals; to the environment, offering relevant personal
language; to the user's internal states, adjusting signals based on drowsiness, medications, physical and
cognitive abilities; and to users' learning patterns from BCI introduction to expert use.
Three specific aims are proposed: (1) Develop and evaluate methods for optimizing system and user
performance with on-line, robust adaptation of multi-modal signal models. (2) Develop and evaluate methods for
efficient user intent inference through active querying. (3) Integrate language interaction and letter/word
supplementation as input modalities in real-time BCI use. Four single case experimental research designs will
evaluate both user performance and technology performance for functional communication with 35 participants
with SSPI in the community, and 30 healthy controls for preliminary testing. The same dependent variables will
be tested in all experiments: typing accuracy (correct character selections divided by total character selections),
information transfer rate (ITR), typing speed (correct characters/minute), and user experience (UX) questionnaire
responses about comfort, workload, and satisfaction. Our goal is to establish individualized recommendations
for each user based on a combination of clinical and machine expertise. The clinical expertise plus user feedback
added to active sensor fusion and reinforcement learning for intent inference will produce optimized multi-modal
BCIs for each end-user that can adjust to short- and long-term fluctuating function. Our research is conducted
by four sub-teams who have collaborated successfully to implement translational science: Electrical/computer
engineering; Neurophysiology and systems science; Natural language processing; and Clinical rehabilitation.
The project is grounded in solid machine learning approaches with models of participatory action research and
AAC participation. This project will improve technologies and BCI technical capabilities, demonstrate BCI
implementation paradigms and clinical guidelines for people with severe disabilities.

Public health relevance
PROJECT NARRATIVE The populations of US citizens with severe speech and physical impairments secondary to neurodevelopmental and neurodegenerative diseases are increasing as medical technologies advance and successfully support life. These individuals with limited to no movement could potentially contribute to their medical decision making, informed consent, and daily caregiving if they had faster, more reliable means that adapt to their best access methods in communication technologies, as proposed in BCI-FIT. This project implements the translation of basic computer science and engineering into clinical care, supporting the proposed NIH Roadmap and public health initiatives.